Maintenance of the Colorado Animal Feed Regulatory Program Standards (U18)

Maintenance of the Animal Feed Regulatory
Program Standards (AFRPS) Project (U18)
PAR-20-132
Colorado Department of Agriculture
Inspection & Consumer Services Division
CDA-ICS Animal Feed Program
Project Summary/Abstract
The Colorado Department of Agriculture (CDA) is committed to maintaining the
implementation of the FDA’s Animal Feed Regulatory Program Standards (AFRPS) as part of
the critical elements of creating a national, fully integrated feed safety system. The CDA
currently has two FDA feed inspection contracts (Medicated Feed and BSE/Feed Safety) in
place and we have nine (9) staff members that are FDA-credentialed inspectors. The Animal
Feed Program (“the Feed Program”) is an organizational unit within the CDA’s Inspection &
Consumer Services Division (“the Division”).
The Feed Program is applying for FDA funding under this cooperative agreement to enhance
our program by maintaining the implementation of the Animal Feed Regulatory Program
Standards (AFRPS). This will be accomplished through assessment and revision of current
procedures and policies, providing training to the inspection staff, and evaluating the
adoption of 21 CFR 507. The Feed Program will also support the CDA Biochemistry laboratory
through the collection of samples under the Flexible Funding Model. Funding from this grant
will also allow CDA staff to contribute to the continuous improvement of the AFRPS through
attendance at annual face-to-face meetings, active participation in committees, and other
initiatives supporting the AFRPS.
The Feed Program has completed the implementation of the AFRPS standards. The cost of
maintaining the implementation of the AFRPS is burdensome and consumes funds from the
Feed Program licensing and tonnage fees that would otherwise go into feed sampling and
testing. CDA is enthusiastic about this opportunity for FDA support to off-set some of these
costs and enhance our feed inspection program.
A significant challenge to the Feed Program is finding dedicated time and resources to
maintain program standards while at the same time meeting the day-to-day workload
demands of the program. Receiving this cooperative agreement would provide additional
resources, specifically in areas of training, auditing, and assessing and revising policies and
procedures. Currently, the Feed Program does not have enough staff focused solely on
making these improvements. This grant would provide additional focused resources for
maintenance of the standards.
Another significant challenge for the Feed Program is in providing the travel funds necessary
to send inspectors to training. This cooperative agreement would significantly increase our
ability to develop an inspection staff trained in the Standard 2 curriculum, as well as PCs
and CGMPs.

Public health relevance
Colorado AFRPS Maintenance Grant Project Narrative This application is for the funding of maintaining AFRPS implementation for the Colorado Feed Inspection Program.